EVALUATION OF TUMOR NECROSIS FACTOR (TNF) ASSAYS

The GCRC CDMAS resource will be used to collect and analyze data generated by a tumor necrosis factor (TNF) bioassay developed by the investigator for the determination of the gonococcal molecules that mediate attachment to human fallopian tube mucosa.